Deciphering the Molecular Features Underlying LRP1-Mediated Tau Spread

Several neurodegenerative diseases, such as Alzheimer’s disease (AD), are characterized by the spread and
aggregation of the protein tau. Recently, we identified a cellular receptor, LRP1 (Low-density lipoprotein
Receptor-related Protein 1), that regulates the tau spread pathway. Knockdown of LRP1 prevents tau spread
in human iPS neurons and the mouse brain, suggesting that the tau-LRP1 interaction could be an important
entry point for disease intervention. Unfortunately, a detailed understanding of the tau-LRP1 molecular complex
is still lacking. Therefore, the main objective of this project is to define the tau-LRP1 structural interface and
discern how post-translation modifications (PTMs) to tau’s structure influence tau uptake and spread. In
preliminary work, we have developed protocols to purify and measure interactions between tau and LRP1. We
have established cellular platforms to model tau propagation and have shown that this process can be influenced
by tau PTMs. To fully develop this work, we propose three aims. In Aim 1, we will use TR-FRET to establish in
vitro affinities between tau and LRP1 and mass spectrometry to map the protein-protein interface. In Aim 2, we
will look at how tau phosphorylation can influence the tau-LRP1 complex and what effect this has on tau spread
and aggregation. In Aim 3, we will focus on tau PTMs that alter lysine residues. We will assess if ubiquitination
or acetylation can impact the tau-LRP1 interaction, if they influence tau aggregation, and if they promote or inhibit
tau uptake and seeding in cells. The innovative experimental methods and comprehensive analyses outlined
herein will provide important mechanistic insight and develop our understanding of pathogenic tau regulation in
AD. This will be an essential first step forward for the development and evaluation of potential AD therapeutics.

Public health relevance
There are currently no effective treatments for tauopathies, such as Alzheimer’s Disease (AD). Uptake and spreading of pathogenic tau is recognized as a key driver of AD pathology, and is primarily mediated by tau's interaction with the cellular receptor LRP1. Molecular dissection of the tau-LRP1 interaction will enable us to devise new therapies for AD.